Imaging Molecular Level Details of Collagen Fibers by VSFG Microscopy

Project Summary
I plan to add a single hyperspectral detection unit to a new nonlinear vibrational microscope developed in
my lab. This detection unit is composed of a spectrograph and an electron-multiplying charge-coupled
device (EMCCD) camera. This unit will enable single-molecule/super-resolution vibrational imaging. We
will carry out the research in two stages. The first stage is to verify that the new vibrational imaging
technique can detect vibrationally encoded photoluminescent signals of single molecules in standard
samples. The second stage uses this single-molecule capacity to image biological systems with a sub-
diffraction-limit optical resolution of <300 nm. This new development will revolutionize infrared imaging
techniques by enabling unprecedented single-molecule sensitivity. Furthermore, this new single-molecule
imaging technique can overcome the issue of limited color channels in photoluminescence (PL) based
microscopy. Our long-term vision is to enable new hyperspectral imaging techniques for biophysical and
biomedical applications, with unprecedented multiplexing color channels and a new approach of super-
resolution imaging that can follow the time evolution of molecular functional groups during metabolism
and other biological processes.

Public health relevance
PROJECT NARRATIVE The proposed project aims to establish single-molecule detection of a new imaging technique based on measuring molecular vibrations. Success would enhance the multiplexity of single-molecule microscopy, and open doors for new super-resolution vibrational imaging that is applicable to biological tissues, cells and extracellular matrices.